VA Summer Undergraduate Research Fellowship (SURF)

The participation of underrepresented (UR) individuals in the biomedical sciences, as well as in Science,
Technology, Engineering, and Mathematics (STEM) in general, remains a critical issue affecting our nation’s
medical and research enterprises. Projections based on 2014 U.S. census data indicate that the demographics
of our nation’s population will change dramatically in the next fifty years. Also, UR researchers may be more
inclined and better positioned to address diseases that disproportionately affect the population they represent.
As such, a diverse healthcare and biomedical research workforce is critical to link scientific advancements with
quality health service and delivery in increasingly diverse communities. Programs such as SURF-Charleston,
start early in a student’s career with the goal of stimulating interest in STEM and will provide exposure to
“hands-on” research opportunities through the lens of what the VA has to offer across all aspects of the VA
Office of Research and Development, including broad and targeted research in basic laboratory sciences
(BL), clinical science (CS), rehabilitation research (RR), and health services (HS) research. SURF-
Charleston will provide critical and highly relevant real-world experience capable of igniting interests and
enhancing perspectives of the innerworkings of science and its integration with clinical care, particularly in the
VA enterprise, beyond what can be received through a typical undergraduate curriculum. To begin to address
this educational gap, we have developed a comprehensive program with the following Specific Aims: 1) Train
early career undergraduates in scientific and soft skills required for successful subsequent professional
educational programs (e.g., M.S., R.N., D.M.D., M.D., Ph.D., M.D./Ph.D.); 2) Introduce the VA research program
through hands-on research experiences under the guidance of successful VA Mentors; 3) Enhance
diversity within the VA medical and research workforce; 4) To coordinate with other SRP sites to develop
best practices and procedures for a successful summer research program. We believe that by initiating
training and exposure early, through this undergraduate research program, we will plant seeds that will continue
to grow throughout the trainee’s educational experience, highlighting the past successes and emerging
opportunities for funding, and support within the VA Health Care System and the Office of Research and
Development (ORD) and priming them with the knowledge of how research discoveries can be applied to
improve clinical care for Veterans.

Public health relevance
This summer research training program, named the Summer Undergraduate Research Fellowship (SURF) Charleston is designed to continue to support a highly successful program based on an ongoing ORD-funded pilot to provide multidisciplinary training opportunities across all ORD portfolios. The purpose of this program is to train the next generation of transformative investigators, and provide them with research experiences through exposure to educational opportunities, as well as new experimental strategies, novel technologies, and medical applications in the context of the VA research program. The primary objective for our program is to promote access for underrepresented populations to graduate education and to enhance specific skills that are required for success in subsequent professional educational programs, while promoting the benefits of a research career within the VA enterprise.